TASK D10: A PHASE 1 TRIAL TO EVALUATE A TREATMENT FOR CLOSTRIDIOIDES DIFFICILE

The Early Phase Clinical Trial Units provide a vehicle for investigation of new agents in the treatment and prevention of infectious diseases and can carry out all aspects of interventional clinical trial implementation.